DEVELOPING SUPERCOMPUTING FACILITIES FOR BRAIN IMAGE ANALYSIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This institute has expertise in developing and porting applications on the supercomputing infrastructure. We plan to create infra structure for brain image analysis.